Novel Role Of ACTN4 in Sodium Reabsorption and Salt-Sensitive Hypertension

PROJECT SUMMARY
The Na+/K+/2Cl- co-transporter (NKCC2) is the main sodium transporter in the medullary thick ascending limb
(mTAL), and enhanced activity of NKCC2 has been linked to hypertension in animal models and humans. We
recently found mutant ACTN4—a cytoskeletal protein previously known to contribute to human podocyte
dysfunction and glomerular disease—leads to salt sensitive hypertension in a novel rat model. ACTN4 is
expressed in mTAL, and we found in our new adaptation of organ-on-chip technology, mTAL-on-chips, that
mutant ACTN4 contributes to increased sodium uptake within mTAL cells via enhancing NKCC2 activity. Our
long-term goal is to define the role of ACTN4 in regulating sodium homeostasis and blood pressure salt
sensitivity. The overall objective of this application is to determine the degree to which disease-causing mutant
ACTN4 influences sodium handling in mTAL. Our central hypothesis is that mutant ACTN4 alters the F-actin
cytoskeletal network, which in turn disrupts normal trafficking of NKCC2 within mTAL cells. This disruption of
trafficking leads to accumulation of NKCC2 on the apical membrane of mTAL cells, elevated sodium reabsorption
in mTAL, and ultimately salt-sensitive hypertension. Aim 1 will determine the degree to which mutant ACTN4
increases salt-sensitivity in mTAL cells. We will use mTAL-on-chips seeded with wild type (WT) mTAL cells and
mutant ACTN4 mTAL cells. We will measure sodium reabsorption of mTAL cells in response to varying levels of
stress, including increasing sodium concentration, shear stress, and stretch. Aim 2 will elucidate the mechanism
by which mutant ACTN4 disrupts NKCC2 trafficking. We will measure differences between WT mTAL and mutant
ACTN4 mTAL cells in (1) the cell surface NKCC2 levels and (2) NKCC2 trafficking (endocytosis and exocytosis).
We will further measure whether these differences are amplified in response to varying levels of stress. Aim 3
will ascertain whether in vivo salt-sensitive hypertension associated with mutant ACTN4 is mediated by NKCC2.
We will examine the effect of mutant ACTN4 on pressure natriuresis. We will also assess the effect of inhibiting
NKCC2 with furosemide on acute natriuresis and blood pressure salt-sensitivity. The research proposed in this
application is innovative in that it integrates the novel mTAL-on-chip technology with advanced imaging and
whole animal physiologic studies to comprehensively delineate the mechanism by which mutant ACTN4 leads
to salt-sensitive hypertension. This research will provide strong evidence of a novel and essential mechanism of
sodium and blood pressure regulation performed by the cytoskeletal protein ACTN4.

Public health relevance
PROJECT NARRATIVE This project focuses on studying a new mechanism leading to salt-sensitive hypertension, which contributes to substantial morbidity, mortality, and healthcare costs. The proposed research will study a novel role of a cytoskeletal protein—previously known to be linked to glomerular disease— in sodium homeostasis and blood pressure regulation. Defining the role of this protein in salt-sensitivity will provide critical insights into salt- sensitive hypertension, laying the foundation for future targets for anti-hypertensive therapy.